Role of Circadian Rhythms and Sleep Disorders in Perioperative Neurocognitive Disorders Trajectories

PROJECT SUMMARY/ABSTRACT
Perioperative neurocognitive disorders (PND) pose a significant public health problem for patients, leading to
detrimental consequences, including increased healthcare costs, functional disability, and long-term cognitive
impairment. Understanding its pathogenesis is an area of active research, much of which is focused on the
physiological impact of surgery and anesthesia on the central nervous system (CNS). Disruption of circadian
rhythms and sleep interferes with biological processes integral to health and the CNS. We observed that patients
with sleep disorders have injuries in multiple brain sites that are further exacerbated by surgery. We documented
that surgery/anesthesia ignites the underlying brain lesions, leading to an attendant decrease in performance in
several cognitive domains. Recent genetic studies point to shared links between sleep and brain health. Whether
genetic variations of circadian rhythms and sleep affect PND remains unexamined.
My research program will use a multifaceted approach to advance our understanding of perioperative cognitive
trajectories, with the goals for the next five years to 1) implement a comprehensive, perioperative neurocognitive
assessment program that is accessible to a diversity of populations; 2) gather, analyze, and characterize
perioperative sleep/activity abnormalities; 3) identify genetic variants that might play a role in hastening the
development of PND. My past and ongoing work incorporates new tools and models to harness and implement
technological innovations to understand the mechanisms and risk factors involved in the origins and trajectories
of PND. I am well-positioned to lead this research program, with a proven track record, within an excellent
institutional environment, and with current and future collaborators positioned to contribute to this program with
expertise in genetic studies and circadian phenotyping. Highlights of expected outcomes: 1) collection and
analyses of high volumes of comprehensive cognitive data that will provide for the development of prehabilitation
programs; 2) causal associations between perioperative sleep disorders and cognitive impairment that will initiate
sleep optimization programs and novel therapeutic targets; 3) identification of genetic risk for PND; and 4)
discovery of novel mechanisms, pathways, and interactions that may lead to the development of pharmacological
interventions. The successful execution of this proposal will produce an innovative framework linking genetic
variants with PND and lead to therapeutic strategies that will improve brain health for all populations.
In line with the mission of the NIGMS, the goal of this proposal is to lay the research foundation for understanding
the interconnected biological processes between PND and sleep, while advancing the diagnosis, treatment, and
prevention of these intractable and devastating diseases. Effective prevention strategies for PND will improve
the overall health, lifespan, and well-being of surgical patients and communities, help dampen the skyrocketing
healthcare costs, and disrupt the cycle of disability and long-term care after surgery.

Public health relevance
PROJECT NARRATIVE/PUBLIC HEALTH RELEVANCE There is an urgent need to develop strategies to improve perioperative brain health. This research program provides for a multifaceted approach toward the implementation of a comprehensive assessment program within the perioperative period that is accessible to all of our nation’s populations while discovering genetic variants that might play a role in the development of perioperative neurocognitive disorders. This work will increase our understanding of the interconnected biological processes of circadian rhythms and sleep disorders and perioperative neurocognitive disorders trajectories and will lay the foundation for the development of both clinical interventions and novel therapeutic targets.